VA RR&D Center for Neurorestoration and Neurotechnology

The VA RR&D Center for Neurorestoration and Neurotechnology (CfNN) at the Providence VA
Healthcare System (VAPHS) unifies a distinguished team of scientists, engineers and clinicians from the
VA, Brown University, and affiliated hospitals to discover, design, develop, and deploy novel
neurotechnologies and device-based therapies that advance the rehabilitation of Veterans with
impairments in mobility, communication, mental health, and limb function. CfNN’s three Focus Areas are
each dedicated to performing the rigorous, peer-reviewed science that leads to new diagnostic,
rehabilitation, and therapeutic strategies for Veterans with spinal cord injury, stroke, amyotrophic lateral
sclerosis (ALS), epilepsy, limb loss, post-traumatic stress disorder (PTSD), depression, and other
nervous system diseases or injuries. CfNN’s three Focus Areas are: (1) Restoring Communication and
Mobility, (2) Restoring Mental Health, and (3) Restoring Limb and Sensory Function. The Focus Areas’
interdisciplinary research efforts are supported by three Cores providing essential infrastructure and
specialized services: (A) Neuroimaging (B) Recording, Decoding, and Computational Neuroscience, and
(C) Assessment, Outcome Measurement, and Implementation. CfNN research is further facilitated by a
dedicated Administrative Team who support scientific productivity, coordinate the synergistic
relationships between CfNN and its academic and clinical affiliates, maintain close contact with local and
national VA officials, and optimize our research in service to Veterans. CfNN’s Strategic Plan and
Research Strategy maximize interactions via complementary expertise and resources among its Focus
Areas and Cores. This in turn supports a high-impact research community focused on application of
medical devices to neurologic health, both within the VA and in the wider regional and national brain
science community. Through this renewal, over the next five years CfNN will leverage and expand its
collaborative research, both within VA Providence and together with other VA Centers, toward
rehabilitation goals important to the large number of affected Veterans and their families. These goals
include: restoring arm and leg function for Veterans with stroke, spinal cord injury, or amputation;
improving and maintaining intuitive, rapid communication for Veterans with ALS; improving the
understanding, early detection, and management of seizures; and more effectively treating Veterans
with PTSD, depression, obsessive-compulsive disorder, or other severe disorders of mental health.
CfNN also aims to develop, validate, and disseminate the outcomes measures needed for effective
clinical trials of new restorative neurotechnologies for these conditions. In addition to the research of its
investigators, CfNN facilitates the training and research careers of outstanding early career researchers,
seeking to recruit them together with established clinicians, scientists, and engineers to focus their
research efforts on improving rehabilitation for Veterans with nervous system disease or injury. CfNN is
committed to providing seed funding for pilot studies to enable affiliated investigators to launch
promising research and collect preliminary data to inform and strengthen larger research projects,
thereby strategically leveraging VA resources toward enabling the larger public and private investments
required for pivotal demonstrations of clinical utility. Through its close association with Brown University,
CfNN provides educational opportunities to undergraduates, graduate students, neuropsychology
interns, and postdoctoral researchers to learn more about the VA, inspiring them to shape their careers
toward not only gaining a better understanding of fundamental human neuroscience, but toward using
that knowledge to improve Veterans Health and rehabilitation.

Public health relevance
Disorders of the brain and nervous system, including those resulting directly from injuries incurred during military service, are of immediate relevance to Veterans Health. In part because of the complexity of the nervous system, people who have disorders such as spinal cord injury, stroke, post-traumatic stress disorder, amyotrophic lateral sclerosis, or limb loss lack adequate rehabilitation therapies to regain their independence. Through rigorous translational and clinical research conducted by a multidisciplinary team of scientists, engineers, and clinicians, the VA RR&D Center for Neurorestoration and Neurotechnology develops and tests novel device-based approaches to improving the health and lives of Veterans. An explicit goal of the Center is to translate neurotechnology and its applications into clinical practice in service to our Veterans and civilians throughout the US.